Alcoholism and Stress: A Framework for Future Treatment Strategies

Stress is a risk factor for alcohol use disorders (AUDs). This is a multi-year R13 application to support
investigators from the United States and enable them to attend the International Conference entitled
“Alcoholism and Stress: A Framework for Future Treatment Strategies” in 2020 and 2023. These are the
fifth and sixth Conferences, sequel to our highly successful meetings on Alcohol and Stress that were held
in Volterra in May 2008, 2011, 2014 and 2017. This Congress series is one of the first international
meetings directed at bridging ongoing independent programs on stress and alcoholism mechanisms in
Europe and the USA. This conference provides a venue for the interaction of a broad group of biomedical
researchers, and as a result, we expect that it will be of broad interest to basic and clinical researchers
around the world.
The meeting will be held on May 5-8, 2020 in Volterra, Pisa, Italy. The attractive location of the meeting will
provide an excellent opportunity for scientists from the USA to present and discuss their cutting edge
research with international colleagues and also provide opportunities for new collaborative research. The
target audience consists of clinicians and researchers interested in the advancement of biomedical
research on stress and AUDs with the goal of developing new and innovative treatment strategies. This
meeting will give participants the chance to present their latest findings related to alcohol and stress
research through posters, symposia, roundtable discussions, as well as plenary lectures. Notably, it will
provide a unique opportunity for alcohol researchers from all over the world to meet on a personal level and
interact with clinical researchers to develop drug strategies for alcoholism treatment. The meeting will also
foster alcohol-related research collaboration within a community that otherwise would have had limited
access to such a venue and body of knowledge (this includes the European countries). Approximately 150
attendees are expected from all over the world, including, but not limited to the following countries: Russia,
Australia, Canada, China, France, Germany, Japan, Spain, Sweden, United Kingdom, and the USA.
This multi-year R13 application requests funding for travel expenses (US carrier economy fare) for up to 30
US scientists to attend this important meeting on stress and alcohol. Preference would be given to
students, post-docs, early career investigators with little or no other funding sources and scientists from
areas with few resources to fund such a trip. Priority will be given to individuals who belong to the
scientifically and medically underserved populations and communities, as we have done in previous
meetings. This application also requests partial coverage of travel expenses for two invited plenary
speakers and for publication costs.

Public health relevance
Alcohol abuse and anxiety disorders are global health problems. This proposal is for the organization of an international conference that aims to bridge ongoing independent research programs on alcoholism and stress, with the overall goal of developing treatment strategies for alcoholism. This meeting will allow participants the opportunity to present current cutting-edge results in the alcohol and stress fields, and will also allow researchers to identify and forge collaborative efforts between European and American research programs.